Trans-BBB AAV9 gene therapy targeting CNS neuropathy of MPS I

Project Summary
The goal of this Phase II SBIR project is to further develop an effective gene replacement therapy product for
treating Mucopolysaccharidosis (MPS) I, towards clinical application and commercialization.
MPS I is a rare lysosomal storage disease (LSD) caused by autosomal recessive defects in α-L-iduronidase
(IDUA). The severe form of MPS I (MPS IH, Hurler syndrome) represents the majority of known cases, with
premature deaths usually before age 10 years, predominantly due to neurological impairments and cardio-
respiratory failure. No effective treatment is available for neurological indications of MPS IH. Because of the
global diffuse neuropathy and the blood brain barrier (BBB), MPS IH is not amenable to either recombinant
enzyme replacement therapy (ERT) or bone marrow transplantation, which are the standard of care for treating
somatic symptoms of MPS I. Gene replacement therapy (GRT) targeting the root cause has been
demonstrated to be an ideal strategy for treating monogenic diseases. Numerous studies have demonstrated
success in IV or intrathecal (IT) delivery of trans-BBB-neurotropic AAV9 targeting the root cause for treating
neurogenetic diseases. Importantly, the efficacy and safety profiles of IV and IT rAAV9 delivery have been
demonstrated to be highly reproducible across different neurogenetic diseases, including LSDs.
For optimal therapeutic potential, we have developed a novel self-complementary (sc) AAV vector, scAAV-
mCMV-∆hIDUAop, to deliver a miniaturized human IDUA cDNA with codon-optimization. The scAAV-∆hIDUAop
vector was shown to significantly enhance the expression and secretion of functional IDUA protein, compared
to the previous single-stranded (ss) rAAV-hIDUA construct. We further tested the scAAV-mCMV-∆hIDUAop
GRT product in pre-clinical studies in MPS I mouse model using AAV9 in Phase I STTR project. With an IV
injection of scAAV9-mCMV-∆hIDUAop vector in MPS IH mice, we achieved functional correction and reversal of
neurological and somatic disorders of MPS I, without detectable toxicity, strongly support the therapeutic
potential of the proposed scAAV9-mCMV-∆hIDUAop vector product for treating MPS I in humans. Further, our
data allowed us to identify the minimal effective dose (MED). We believe that we are well-positioned to move
forward towards a Phase I/II IND. In this Phase II SBIR project, we will hold the Pre-IND meeting, complete the
IND-enabling toxicology studies and submit an IND application to the FDA for approval of a Phase I/II clinical
trial in patients with MPS I.

Public health relevance
Project Narrative This STTR project targets the unmet need for mucopolysaccharidosis (MPS) I, a devastating fatal disease in children. Targeting the root cause, we have developed an effective gene replacement therapy using adeno- associated viral vector to treat both the neurological and somatic disorders of MPS I via a systemic delivery. The goal of this Phase 2 SBIR is to further develop this gene therapy product for the treatment of MPS I in patients towards clinical application and commercialization.